SEER RESEARCH SUPPORT REGISTRIES PROGRAM LINKAGES AND DATA MANAGEMENT SUPPORT

The SEER Program seeks to enhance the quality and completeness of data collected through the use of various projects and data sources. Colorado is a Research Support Registry and is not contracted to provide data twice annually to the SEER Program. However, Research Support Registries are able to receive task order awards to participate in SEER supported projects. This task order award is to enable participation in two SEER supported projects as well as enable the use of SEER*DMS Lite for aspects of the data collection effort.